The role of intestinal SCD1 in regulating metabolic health

The intestine is emerging as a regulatory and signaling organ, enabling diet-derived nutrients to perform
essential actions. A better understanding of intestinal regulation of systemic lipid metabolism has direct
implications to multiple human metabolic pathologies, including cardiovascular disease, fatty liver, and insulin
resistance. The delta-9 desaturase, stearoyl-CoA desaturase-1 (SCD1), converts saturated fatty acids to
monounsaturated products and has been shown to regulate lipid esterification in liver and skin. However,
virtually nothing is known about the role of SCD1 in the intestine, where lipid esterification is crucial for its
eventual absorption and secretion into chylomicrons (CMs). To address this gap in knowledge, we generated
mice with a targeted deletion of SCD1 only in intestinal epithelial cells (iKO mice). Remarkably, we find that
iKO animals have significant reductions not only in intestinal lipids, but also in circulating and hepatic lipid
levels, particularly in levels of monounsaturated fatty acids. iKO mice also have significant increases in both
energy expenditure and glucose tolerance, accompanied by increased thermogenic markers in brown adipose
tissue and increased plasma GLP-1 levels. Unexpectedly, intestinal SCD1 deletion elevates plasma and
hepatic bile acids (BAs) and alters markers of hepatobiliary BA efflux and ileal BA reuptake. Supported by
these and other compelling preliminary data, this application will assess the role of intestinal SCD1 in
integrating metabolic signals originating in the gut. The central hypothesis of this application is that intestinal
SCD1 regulates metabolic health by altering secreted lipid content and composition, TGR5 signaling in BAT
and the gut, and enterohepatic BA metabolism. This hypothesis will be tested by our two related but
independent Specific Aims. In Aim 1, we will test the relevance of intestinal SCD1 inhibition to energy balance
in the context of hypercaloric and hyperlipidemic diets. We will also evaluate a mechanistic role for TGR5 in
mediating the improved metabolic phenotypes of iKO mice. In Aim 2, we will evaluate a role for SCD1-derived
MUFAs in regulating hepatic BA efflux and intestinal BA reuptake . We will also utilize a) an inhibitor of
intestinal BA reuptake, b) a gut-restricted FXR agonist, and c) dietary MUFAs to restore hepatic and plasma
BA levels in iKO mice.

Public health relevance
The intestine is an important regulatory and signaling organ, enabling diet-derived nutrients to perform essential actions. In this project, we explore a novel role for an intestinal lipid-metabolizing protein, stearoyl- CoA desaturase-1 (SCD1), in regulating whole body lipid levels and metabolic health. These studies have important translational implications to the development of novel nutritional and pharmaceutical therapies for maintaining and improving cardiometabolic health.